The Impacts of Adverse Provider Conditions on Provider Bias and Health Disparities

Project Summary
Healthcare disparities that adversely affect patients from racial and ethnic minoritized groups are often attributed
to provider level factors such as implicit bias. However, efforts to reduce disparities have been hindered by an
incomplete knowledge of factors that leave providers more vulnerable to bias and their underlying mechanisms.
This proposal will address this critical knowledge gap by identifying situations that increase bias among
healthcare providers that can be intervened on at the provider and system level. The proposed research
leverages theory from psychology and psychoneuroimmunology to document the impact of three adverse
provider conditions (APCs) that could increase provider bias: (1) workplace demands (e.g., heightened levels of
stress or burnout), (2) concerns about one’s own health, and (3) increased inflammation occurring during illness.
We hypothesize that when providers experience higher (versus lower) workplace demands, are more (versus
less) concerned about their own health, and experience higher (versus lower) acute inflammation, they will
demonstrate more bias against patients from racial and ethnic minoritized groups. We will test our hypothesis in
the context of abdominal pain treatment in emergency departments. Participants will be attending physicians,
nurse practitioners, physician’s assistants, and residents in emergency medicine and internal medicine
hospitalists who treat abdominal pain for patients who are admitted. We will address three specific aims to
document effects of APCs on quality of care disparities. To address Aim 1, we will use a correlational design to
determine the relationship between APCs and standardized assessments of bias (implicit and explicit bias,
perception of others’ pain, and social avoidance). To address Aim 2, we will use a randomized controlled
intervention design; we will use the influenza vaccine to simulate illness by experimentally increasing
inflammation (indexed by pro-inflammatory cytokine levels). Increases in cytokines are hypothesized to be
positively associated with standardized assessments of bias. To address Aim 3, we will use a prospective,
longitudinal design to tracks provider illness symptoms, stress, burnout, and local cases of infectious illness over
the course of a year. These provider data will be correlated with patient data from abdominal pain cases treated
by the provider on those days. This study has high ecological validity and findings will identify distinct
contributions of APCs to lower quality of care, especially for patients from racial and minoritized groups. Overall,
the proposed research will have widespread positive impact by outlining paths for novel interventions at multiple
levels and domains of influence within the NIMHD Research Framework, such as by engaging administrator and
clinical management stakeholders in conversations about consequences of staffing policies for health disparities.

Public health relevance
Project Narrative The primary goal of the present proposal is to use a rigorous multi-method approach to determine how and when adverse provider conditions (e.g., burnout, illness, concerns about own health, and inflammation) lead to lower quality of care, especially for patients from racial and ethnic minorit ized groups. The proposed research points to potential and novel sources of bias that have time-dependent opportunities for intervention, distinct from (but complementary to) traditional approa ches to implicit bias training. Moreover, the proposed research will provide additional, novel evidence supporting the importance of addressing system-level issues of inadequate staffing and provider burnout.